Cell Imaging Shared Resource

CORE 004 – CELL IMAGING SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
The mission of the Cell Imaging Shared Resource (CISR) is to serve the Vanderbilt-Ingram Cancer Center
(VICC) research community, inclusive VICC member and partners at Meharry Medical College, Tennessee State
University, and other NCI Cancer Centers. CISR provides access to cutting-edge technology and expert
technical support for microscopic observation and analysis of tissue and cellular anatomy and physiology
essential to modern cancer research. The CISR maintains the full range of advanced microscopy and digital
imaging capabilities fundamental to current cancer research methodology. CISR services have supported
significant numbers of studies relevant to the mission of the VICC. Results from CISR services have been
included in more than 130 VICC investigator publications during the past three years. Steady progress in
microscopy-related research support of VICC investigators continues to facilitate high-quality data acquisition,
storage and analysis. VICC leadership works closely with the CISR on customer surveys that allow efficient
strategic planning and operational oversight. The CISR recently added a Nikon Spinning Disk Confocal
microscope, a Nikon Structured Illumination microscope (SIM), a Zeiss LSM880 with Airy Scan confocal
microscope, a Nikon Total Internal Reflectance Fluorescence (TIRF) microscope, and an upgrade to the existing
Nikon Stochastic Optical Reconstruction Microscope (STORM), which will keep the shared resource at the
forefront of new technology. Moreover, through a Vanderbilt Trans-Institutional Project (TIPS), Matthew Tyska,
PhD along with colleagues in Biomedical Engineering and Physics established a new collaboration to advance
microscopy by building a Lattice Lightsheet (LLS) microscope that is now available to the Vanderbilt community.
Plans include the construction of three more LLS microscopes to provide VICC investigators with state-of-the-
art microscopy of live cells. The CISR, founded as a Cancer Center Microscopy Core in 1993, is a successful
model for efficient utilization of expensive resources and dedicated expertise. VICC investigators continue to
obtain both significant cost advantages and vital access to a large array of valuable, advanced instrumentation
and dedicated expertise from the CISR, thus enabling and accelerating cancer research that would otherwise
be reduced in quantity and quality. The expert staff in the CISR also ensures that trainees learn best practices
for handling microscopes and for acquiring the best images possible in a quantitative and rigorous manner that
is reproducible.

Public health relevance
CORE 004 – CELL IMAGING SHARED RESOURCE PROJECT NARRATIVE Per the PAR-17-095 FOA, the project narrative is not applicable for the Cell Imaging Shared Resource.